Enhancing treatments for myeloid leukemia associated with Down syndrome

PROJECT SUMMARY
Myeloid Leukemia associated with Down syndrome (ML-DS) patients have high 5-year overall survival (OS) rates
when treated exclusively with cytarabine (AraC)-based protocols. While many notable factors linked to the high
curability of ML-DS have been made, the molecular mechanisms are not entirely understood. The bone marrow
microenvironment plays a role in overall leukemogenesis. We have demonstrated endothelial cells (ECs)
modulate non-DS AML growth and chemoresistance. However, their impact on the chemosensitivity of ML-DS
cells has yet to be fully understood. We have demonstrated that AML-induced EC activation in the bone marrow
leads to subsequent leukemia cell adherence and chemoresistance, identifying this process as integral in the
formation of minimal residual disease (MRD) and subsequent relapse. Interestingly, our pilot data show
significantly decreased interactions between ML-DS cells with non-DS ECs compared to non-DS AML.
Furthermore, it is well documented that ECs isolated from different tissues as well as disease states (normal vs
leukemia) represent heterogeneous populations with varied functional capacities. Based on these overall
findings, we hypothesize that ML-DS is affected by interactions with ECs and the specific activity of ML-DS ECs
play a role in increased response to chemotherapy and reduced relapse rates observed with ML-DS patients.
Understanding this mechanism will provide a deeper understanding of ML-DS. Although ML-DS patients respond
favorably to AraC-base chemotherapy, those that relapse have dismal outcomes despite salvage therapies.
Thus, enhancing the already effective frontline treatments for ML-DS patients may further improve the EFS rates
(already at ~90%) via reducing the risk of relapse. Hydroxyurea (HU) is an inhibitor of ribonucleotide reductase
(RNR). RNR influences the abundance of the active AraC triphosphate metabolite AraCTP. Additionally, it was
recently reported that RNR inhibitors suppress sterile α-motif and histidine-aspartate domain-containing protein
1 (SAMHD1; a deoxynucleotide triphosphohydrolase), preventing SAMHD1 from hydrolyzing/inactivating
AraCTP, resulting in enhanced AraC activity against non-DS AML. Our preliminary studies show that AraC-
resistant ML-DS cell line CMY has substantially increased SAMHD1 compared to AraC-sensitive ML-DS cell line
CMK. Based on the literature and our preliminary data, we hypothesize that HU enhances AraC antileukemic
activity against ML-DS. Our proposed studies will 1) determine the role of the DS bone marrow microenvironment
in ML-DS therapy responses and 2) use HU as an approach to enhance AraC activity against ML-DS cells.
Studying the relationship between DS ECs and ML-DS and AraC sensitivity will improve our understanding of
the mechanisms underlying the extremely high cure rates of children with ML-DS. Additionally, the development
of new AraC enhancing treatments for ML-DS patients may further improve OS rates of children with ML-DS.

Public health relevance
Project Narrative Down syndrome (DS) children have a significantly higher risk of developing acute leukemias compared to non- DS children. The goal of this proposal is to determine the role of the DS bone marrow microenvironment in myeloid leukemia associated with DS (ML-DS) therapy response, furthering our understanding of the mechanisms underlying the extremely high cure rates of children with ML-DS. This proposal will also identify a novel treatment strategy of enhancing cytarabine treatment to further improve treatment outcome and reduce relapse of ML-DS patients.